REhabilitation Promoting Prevention And Improved Resilience (REPPAIR)

To optimize the function and independence of Veterans, it is critical to develop proactive treatments that
ameliorate and prevent disability and the resulting loss of quality of life and high cost health care associated
with the progression of chronic disease. 1 Ideally, these preventative treatments should be designed to target
Veterans at greatest risk and be personalized to their needs. This is critical for the VA since the mean age of
Veterans is 64 years and Veterans manifest greater impairment and functional limitations than their age-
matched civilian counterparts. 2,3 Aspects of personalization include a focus on impairments linked to not only
physical but cognitive function; and acknowledging that critical steps to preventative care include a focus on
behavior change of the patient. 1 Treatments promoting long term success commonly emphasize these
approaches. Rehabilitative care can play a leading role in this model of secondary preventative care. 4
Preventative rehabilitative care is known as prehabilitation. 5 This term traditionally refers to preventative pre-
surgical care and less frequently focuses on prevention and amelioration of disability among Veterans with
chronic disease. However, there is a tremendous unmet need to develop prehabilitative care treatments that
maximize the functional capacity of aging veterans and thereby extend quality of life as well as prevent
disability and excessive health care utilization. The Prehabilitation Center (PreHC) REAP will prioritize the
development of Prehabilitative Care strategies optimizing functioning among Veterans at risk for functional
decline and disability. Through the leadership of three organizational cores and the combination of qualifying
studies and pilot studies, the PreHC will develop a single data repository supporting three programmatic
research aims: 1) It will test the efficacy of novel therapeutic approaches on three important prehabilitative
outcomes (i.e., 3M’s): cognitive function (Mind); physical function (Mobility) and successful behavioral change
(Motivation); 2) It will identify biologic subtypes and phenotypes that mediate treatment response; 3) It will
confirm and validate these relationships using the large data resource derived from our collective studies and
through linkage with data from VA national databases. Our center will advance VA clinical research and
prehabilitative care by providing core resources and training for investigators of all levels. Under the leadership
of the Project Director (Dr. Bean), three operational cores will be created: 1) a Leadership, Capacity and
Advancement Core that will include the administrative leadership of the REAP and oversee all training and
education activities sponsored by PreHC, including administration of the pilot grant program for trainees and
junior faculty; 2) a Scientific Discovery Core that will provide state of the art assessment of neurocognitive
function (mind), physical function (mobility) and measures of behavior change (motivation); and 3) a Data
Management Core supporting the collection, monitoring, management and transfer of complex data, the
development of single data repository resulting from the qualifying and pilot studies and biostatistical support
assisting with study design and analysis. An internal steering committee will help oversee day to day
operations and programmatic success and an external advisory board of content experts will help guide the
achievement of the short- and long-term goals. We will use this resulting information to develop more
personalized Prehabilitative treatment approaches that will be tested for better meeting the personalized needs
of Veterans. Additionally, the resulting data repository will be an available resource for VA-based RR&D
researchers that will develop and grow with advancement of PreHC. In sum, over the next five years, the
PreHC will evolve into a national resource center that will conduct cutting-edge research in prehabilitative care.
The knowledge gained from this research will fill gaps in our current therapeutics to advance and maintain the
long-term health of aging Veterans.

Public health relevance
Typically, rehabilitation is prescribed to improve physical functioning among Veterans recovering from an illness, injury or surgery. It is rarely viewed as a mode of preventative care. However, the average age of US Veterans is 64 years old; and when compared to civilians of the same age, Veterans are more functionally impaired. This puts Veterans at high risk for loss of independence, low motivation and poor quality of life. Therefore, to better serve aging Veterans, we must identify treatments that improve health and independence across the lifespan. We will create a center that focuses on preventative rehabilitative care, which is also known as Prehabilitation. Our Prehabilitation research center will develop personalized treatments that target physical function, cognition and motivation, that can be spread throughout VHA.